Community and big-data system approaches to identifying and understanding the health impact of xylazine

PROJECT SUMMARY
The US opioid crisis has been worsened by the emergence of fentanyl adulterated or associated with the
veterinary sedative xylazine (FAAX). Designated by the White House as an “emerging threat to the US” in 2023,
FAAX exacerbates overdose risk, contributes to severe skin wounds, and is associated with withdrawal.
Naloxone, an opioid antagonist, does not directly reverse xylazine’s sedative effect, exacerbating overdose risk.
Our understanding of how FAAX-related skin wounds appear and are treated is limited, but the effects of these
wounds are profound. Moreover, withdrawal from FAAX and its effect on medication for opioid use disorder, the
treatment of choice for opioid use disorder, is unknown. Further, there is no widely available point-of-care test
for xylazine to inform real-time clinical practice, limiting our ability to link those exposed to FAAX to treatment.
Recognizing the absence of a widely available point-of-care test, the long-term objective of this proposal is to
develop a rule-based natural language processing (NLP) algorithm to identify FAAX-exposed patients. To
achieve this, the applicant proposes an exploratory, sequential, mixed methods study that builds upon his
formative research. Approximately 20-24 in-depth interviews with people who use drugs (PWUD) exposed to
FAAX in Rhode Island (RI) will be conducted to explore FAAX-related overdose, skin wounds, withdrawal
experiences, and self-treatment (AIM 1). Then, 8-10 key informant interviews with medical providers in RI to
PWUD exposed to FAAX will be conducted to understand emergent FAAX treatment practices and iteratively
refine a vocabulary list of FAAX symptom descriptions (i.e., NLP dictionary) following a modified Delphi approach
(AIM 2A). Then, we will apply the NLP dictionary via an NLP algorithm to the free-text electronic health records
of ~24,000 patients (≥18 years old & opioid or injection drug use diagnostic code) who received emergency
department care between 2015-2023 from a RI health system to identify patients exposed to FAAX (AIM 2B).
This fellowship will advance the applicant’s expertise beyond what would developed in his doctoral program and
enable the application of this skill set to an urgent public health priority aligned with NIDA’s Notice of Special
Interest NOT-DA-24-012 (Xylazine: Understanding its use and consequences). Through the sponsorship of an
interdisciplinary team with a collective 40+ years of substance use research and expertise in behavioral sciences,
epidemiology, addiction medicine, and natural language processing, the applicant will complete the proposed
research and the following training goals: (1) receive training in the design, conduct, and analysis of mixed
methods research; (2) grow content knowledge and expertise in substance use and socio-epidemiologic
research methods to end drug-related harms; (3) develop skills in the use of NLP techniques applied to large
datasets; and (4) further the applicants professional development, academic leadership, and scholarly
productivity. Completion of this F31 will position the applicant as a mixed methods behavioral scientist who
applies computational methods to large datasets via NIH-funded research to improve the health of PWUD.

Public health relevance
PROJECT NARRATIVE The proposed study addresses NIDA’s Notice of Special Interest in xylazine, which has worsened the US opioid crisis and is associated with overdose risk, severe skin wound development, and withdrawal. Our understanding of xylazine’s effect on the health of people who use drugs is nascent and there is no widely available point-of- care test to identify patients exposed to fentanyl adulterated or associated with xylazine (FAAX). This study will use an exploratory, sequential, mixed methods design to understand how people who use FAAX experience and self-manage its effects and develop a natural language processing algorithm to identify FAAX-exposed emergency department patients that can be used to link patients to treatment and identify a population of FAAX- exposed patients’ EHR data upon which to explore further lines of inquiry.